Project 1 - Modulation of Tolerance and Autoimmunity by Inhibitory Receptors

PROJECT SUMMARY
Inhibitory receptors (IRs) PD1 and LAG3 play critical roles in regulating T cell tolerance and preventing
autoimmunity, but limit effective immunity against tumors and chronic infections. These IRs are major clinical
targets. PD1 blockade has transformed cancer therapy, and PD1 agonists are in clinical trials for autoimmunity.
Combined LAG3/PD1 blockade recently received FDA approval for melanoma. However, IR blockade may lead
to immune-related adverse events (irAEs). A better understanding of how PD1/LAG3 interact to control tolerance
is needed to determine how to effectively modulate these IRs to activate anti-viral and anti-tumor T cells while
minimizing irAEs, and develop optimal PD1/LAG3 agonists for autoimmunity. Project 1 (P1) will test the
hypothesis that “PD1 and LAG3 enforce tolerance through a combination of overlapping and unique cell-intrinsic
and cell-extrinsic functions in CD4+ and CD8+ T cells to control the balance between pathogenic and protective
T cell responses during autoimmunity”. P1 will use two autoimmune disease models—experimental autoimmune
encephalomyelitis (EAE) and
compare self-reactive T cells in
the non-obese diabetes (NOD) model—to identify shared mechanisms and
two target organs. Aim 1: What are the relative and synergistic roles of PD1 and
LAG3 in controlling self-reactive CD4+ FoxP3- (Tconv) and regulatory T (Treg) cells during EAE initiation and
progression? We hypothesize the relative and integrated functions of PD1 and LAG3 differ during EAE initiation
and progression. We will determine (A) cell-intrinsic functions of PD1 and LAG3 in regulating self-reactive naïve
and effector Tconv; (B) integrated effects of LAG3/PD1 modulation on Treg and Tconv during the course of EAE; and
(C) shared and unique molecular pathways downstream of PD1/LAG3 in CD4+ T cells in EAE. We will use a
combination of CD4+ T cell restricted and inducible PD1/LAG3-deficient model systems and PD1/LAG3
recombinant antibodies. Aim 2: What are the molecules and mechanisms downstream of PD1 and LAG3 that
control self-reactive CD8+ T cells during autoimmune diabetes? We hypothesize there are shared drivers of
exhausted/effector-like CD8+ T cells in autoimmunity, cancer and chronic infection. We will determine: (A) how
PD1/LAG3 interact to control diabetogenic CD8+ T cells; (B) how PD1/LAG3 interact to regulate the balance
between pathogenic and protective T cells during diabetes; and (C) causal genes driven by PD1/LAG3 to
regulate activation, differentiation, and effector functions of diabetogenic T cells. We will use a combination of
CD8+ T cell restricted PD1/LAG3-deficient model systems and PD1/LAG3 recombinant antibodies. In both Aims,
we will use cellular and transcriptomic approaches to assess changes associated with LAG3/PD1 loss in T cells,
and gene perturbation approaches to define mechanisms by which PD1/LAG3 control T cell fate and function.
IR-PPG Interactions: P1 will collaborate with P2 and P3 to define shared and unique mechanisms of LAG3/PD1
function in T cells in autoimmunity, cancer (P2) and chronic viral infection (P3); Core A to exchange data; Core
B to obtain mice; Core C for computational analyses and gene perturbation, and Core D to obtain antibodies.